Rigorous Evaluation of Training in Alcohol-Serving Venues for Sexual Violence Prevention

PROJECT SUMMARY/ABSTRACT
The prevalence of sexual violence (SV) is still unacceptably high in the United States and alcohol-serving
venues (e.g., bars, nightclubs) are the most common public setting where SV occurs 1-3 Extensive research
confirms that the venue environment, coupled with alcohol consumption, is associated with increased rates
of SV.4-6 Trainings for venue staff, which combine bystander intervention skill-building with discussion of
organization-level changes to policies, norms, and environmental characteristics, are a promising approach
to prevent SV because they address both individual and community (i.e., venue)-level risk and protective
factors.7 To date, these trainings have not been rigorously evaluated in terms of SV outcomes. 8, 9 There is a
critical need to test the effectiveness of prevention approaches that change both individual behavior in
venues and characteristics of venue settings to reduce SV among staff and patrons. The proposed study will
assess the effectiveness of Safe Bars active bystander training, which involves training and support for
alcohol-serving venues, for primary prevention of SV. Safe Bars, Inc. has implemented trainings for venue
staff since 2013, with 135 venues in 15 states trained either directly by Safe Bars, Inc. or by one of their
trained chapter organizations since 2022. Grounded in established theories of behavior change, Safe Bars
promotes anti-violence norms and creates safer environments by increasing bystander intervention among
venue staff and generating venue-level solutions to preventing SV (such as improving policies or increasing
anti-violence messaging in the venue). In a prior study, we established the feasibility of evaluating venue-
based SV prevention by conducting an evaluability assessment, including formative research and pilot
testing of procedures. Informed by our results, the proposed evaluation uses a Hybrid Type 1 effectiveness-
implementation design10 to assess the impact of Safe Bars training on SV among venue staff and patrons
(Aim 1); examine venue environment characteristics, staff and patron psychosocial factors, and staff
bystander intervention behaviors as mediators of Safe Bars training effects on SV outcomes (Aim 2); and
examine potential moderating characteristics necessary for effective Safe Bars implementation and improved
staff and patron outcomes (Aim 3). We will use repeated surveys of patrons and staff at 15 intervention and
15 waitlist control venues, semi-structured interviews with managers and staff, training observations, venue
observations, and Safe Bars implementation records to evaluate effectiveness and implementation and
measure costs. Safe Bars training is manualized for dissemination and has shown strong community
acceptability. The outcomes of this study are expected to have an important positive impact by expanding
the evidence base for community-level SV prevention and informing future implementation of venue-focused
interventions.

Public health relevance
PROJECT NARRATIVE This study will rigorously evaluate Safe Bars active bystander training. Safe Bars involves training and support for staff at alcohol-serving venues to improve norms about violence, create safer environments by teaching staff to intervene in potentially harmful situations, and help prevent sexual violence in the venue community. Findings have the potential to expand research evidence for sexual violence prevention programming that targets both individual and community characteristics and can be widely disseminated.